Lung interstitial macrophage remodeling during and after recovery from pneumococcal respiratory infection

Project Summary
Worldwide, acute lower respiratory tract infections, including pneumococcal pneumonia, are a major cause of
mortality among all infectious diseases. Streptococcus pneumoniae continues to be the leading cause of
bacterial pneumonia. Children under the age of two are repeatedly exposed to pneumococcus. These
exposures result in naturally acquired heterotypic immunity. This immunity is protective in adult years, but
eventually wanes with advanced age. The immune-mediated mechanisms of heterotypic protection remain
incompletely understood. Past studies from our lab show that mediators of this protection are concentrated
inside the recovered lung specifically, making it a major priority to understand lung-localized immune cells and
activities. Multiple innate and adaptive immune cells of the lung are profoundly changed after recovery from
pneumococcal infections. Alveolar macrophages (AM) in lungs of pneumococcus-experienced mice exhibit
changes to more than one tenth of their transcriptome, have altered surface marker expression and
metabolomes, and more faithfully resemble human AMs when acutely infected. In contrast, the remodeling and
immune defense roles of lung interstitial macrophages (IMs) are underappreciated. IMs are becoming better
defined, with two subsets (CD206+ and CD206-) found in the mouse lung. CD206+ IMs are posited to have
pro-resolving and anti-inflammatory roles whereas CD206- IMs have genes associated with antigen
presentation. Preliminary data shows both subsets are increased in the recovered lung, with CD206+ IMs
having changes in surface marker expression and enhanced association with bacteria, suggesting a
remodeled phenotype. Therefore, we hypothesize that the remodeled CD206+ IMs contribute to lung immune
defense during and after recurrent pneumococcal exposures. This hypothesis will be tested through two
specific aims: Aim 1) to test the hypothesis that experience remodels lung IMs, and Aim 2) to test the
hypothesis that CD206+ IMs have different functional significance in the experienced lung. Advancing our
fundamental understanding of IM phenotypes in the recovered lung, as well as their immune defense roles, will
be useful for developing host-directed therapies and vaccine-elicited protection.

Public health relevance
Project Narrative The lungs contain a population of cells called interstitial macrophages that are poorly understood compared to alveolar macrophages. Proposed studies will determine whether these cells contribute to protecting the lungs against infection, and if the ways that they protect the lungs change depending on prior lung experiences. The proposed activities in this F31 will help train predoctoral student Elise Armstrong in the biology of lung defense, the principles and practice of rigorous scientific investigation, and professional development skills advancing an academic research career.